Post-transcriptional regulations of proteomes in stress and senescence

PROJECT SUMMARY
Post-transcriptional mechanisms play a fundamental role in regulating gene expression at the protein level,
and are frequently implicated in stress response, aging, and diseases. The goal of this project is to develop
and apply multi-omics methods to examine the post-transcriptional mechanisms that regulate protein
composition of multiple tissues and their ability to respond to proteostatic stressors. In recent work, our team
has developed mass spectrometry and multi-omics methods that are designed to elucidate the protein isoform
composition and spatiotemporal dynamics. Building on these progresses, we will focus here on the roles of
three post-transcriptional mechanisms known to influence protein translation in stress response.
Specifically, Aim 1 will integrate proteomics and transcriptomics data to identify the role of alternative
splicing in modulating principal isoform abundance, creating alternative proteoforms, and influencing protein
localization in mammalian tissues. Aim 2 will determine the differential expression, localization, and targets
of RNA-binding proteins in proteostatic stress responses including paraquat in vivo as well as doxorubicin
and hydrogen peroxide in vitro. Finally, Aim 3 will examine the configuration and interactome of the translation
apparatus including the core ribosome and an increasing number of known ribosome-associated proteins,
which have emerged as important factors that can fine-tune the translational efficiency of individual transcripts
and the associated protein synthesis rates.
The proposed experiments will interrogate the relationships between post-transcriptional regulation
and stress response, and at the same time generate novel data sets including isoform-resolved,
spatiotemporal atlases of the normal, stressed, and aged/senescent proteomes. We anticipate the results will
lead to novel insights into basic cellular processes of stress response and resilience that will be relevant to
studies of multiple systems.

Public health relevance
PROJECT NARRATIVE Cellular function requires the capacity to maintain physiological protein compositions and respond to environmental stimuli. The proposed project will apply large-scale mass spectrometry and proteomics technologies to examine post-transcriptional mechanisms that regulate protein composition and synthesis in mammalian tissues as well as human cell culture models. The results will advance current understanding of how tissues and organisms mount successful responses to oxidative stressors or lose resilience and develop diseases.